Task A71: Comprehensive In Vivo Screening of Viral Pathogens of Pandemic Potential

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.